NorthStar Node of the Clinical Trials Network

7KH SURMHFW DEVWUDFW KDV QRW FKDQJHG IURP WKH RULJLQDO SURSRVDO

Public health relevance
Public Health Relevance Statement: Stigma towards people with opioid use disorder (OUD) among primary care clinicians create barriers to effective OUD treatment. Using a randomized controlled trial, this project will examine whether an online clinical decision support (CDS) training incorporating patient narratives reduces stigma attitudes, increases intentions to treat OUD, and increases use of the CDS tool compared to an attention-control CDS training.